Myeloid cell ferroptosis in hemorrhagic stroke

PROJECT SUMMARY
Hemorrhagic stroke (HS) is a devasting acute injury with less than a 50% 1-year survival rate. Clinically, HS
presents a complex problem, and most medical intervention is focused on maintenance of blood pressure,
coagulation intracranial pressure, edema, inflammation, and oxidative stress. Following acute injury, immune cell
infiltration can promote clearance of the hematoma; however, in many cases can contribute to inflammatory tone
and drive neurodegeneration resulting secondary injury. The immune response in HS is not well understood, and
currently, the literature remains divided the beneficial role of immune cell recruitment in HS. This fellowship
proposes to investigate how myeloid ferroptosis, an oxidative form of cell death contributes to secondary injury
after HS. The central hypothesis of this fellowship is that myeloid cell ferroptosis drives neurodegeneration
during secondary injury after HS. To test this hypothesis, we propose two aims: 1) Drive myeloid ferroptosis by
knockout of glutathione peroxidase 4 (GPX4), the key regulator of ferroptosis, and 2) Prevent myeloid ferroptosis
by knockout of acyl-CoA synthetase long-chain family member 4 (ACSL4). Using a combination of genetic and
pharmacological approaches we will investigate pathological mouse behavior after HS, immune cell response
and polarization to hematoma, and therapeutic intervention after HS. The long-term goal of this proposal is to
identify a subset of responsive myeloid cells that are susceptible to ferroptosis and drive secondary injury after
HS that can be modulated pharmacological to improve HS outcome. We suspect that this paradigm will transcend
HS pathology and may be generalized to other pathologies of oxidative stress providing a novel therapeutic
approach to improve clinical outcomes.

Public health relevance
PROJECT NARRATIVE Hemorrhagic stroke is an acute traumatic brain injury that manifests that manifest in release of blood into the brain parenchyma resulting in sterile inflammation, infiltration of innate immune cells, and neurodegeneration. Currently, there are no FDA-approved pharmacological interventions demonstrated to improve stroke outcome, and current literature presents an unclear role for the innate immune response after hemorrhage. Investigation of the role of ferroptosis in myeloid cells after hemorrhagic stroke will clarify the role of myeloid cells in injury repair after stroke and provide new therapeutic avenues for improved post-stroke recovery.